Administrative core

PROJECT SUMMARY/DESCRIPTION
Core A is critical to the operation of this program project, and has three major aims. In Aim 1, core A will initiate
and organize regular communication between the principle investigators and personnel for each project and
research service core, with a goal to ensure each program element appropriately prioritizes and efficiently
completes high-impact research. In Aim 2, core A will ensure advisory boards provide sufficient program
oversight, both with respect to scientific activities, as well as ensuring the program follows NIH mandated
policy on scientific research. In aim 3, Core A will provide organization and logistical support for the program,
including the administration of all fiscal resources.